ATOPIC DERMATITIS RESEARCH NETWORK (ADRN) CLINICAL RESEARCH CENTER

PROJECT SUMMARY/ABSTRACT
This Atopic Dermatitis Research Network-Clinical Research Center (ADRN-CRC) proposal aims to establish a
clinical and laboratory infrastructure to support the ADRN-Leadership Center (ADRN-LC). The current
proposal will evaluate the endotypes underlying three AD phenotypes: AD patients with propensity to eczema
herpeticum (ADEH+), AD without a history of eczema herpeticum (ADEH-) and AD with food allergy (AD+FA+).
We propose that these different phenotypes and endotypes of AD are associated with different skin barrier
profiles that can be defined by genomics, lipidomics, transcriptome, and proteomics. The project will establish
a clinical and administrative infrastructure of trained clinical staff with capabilities of recruiting adult and
pediatric AD populations, clinical research facilities, investigational pharmacy services, IRB personnel, and
laboratory facility capable of conducting single-center ADRN-CRC and multi-center clinical research for the
ADRN Consortium in the areas of mechanisms and treatment of AD. Here, we propose two CRC-specific
research projects as outlined in this application. Project 1 will focus on mechanisms of disseminated viral
infections in eczema herpeticum. The project will utilize archived and newly established keratinocyte and
fibroblast cell lines from skin biopsies of ADEH+ and ADEH- subjects and non-atopic controls. We intend to
evaluate the role of nine novel ADEH+ genetic risk mutations identified by the study group in anti-HSV-1
responses and keratinocyte differentiation. In addition, the contribution of sphingolipid metabolism and S1P in
HSV replication will be examined. Lastly, epidermal differentiation program of ADEH+ keratinocytes influenced
by prior in vivo exposures to the cytokine environment and viral exposure will be evaluated. Project 2 will
assess skin barrier abnormalities and oxidative stress response in the skin of AD patients with FA. The project
will characterize skin barrier function of AD+FA+ children and adults through clinical and skin tape strip
lipidomic and proteomic assessment. Evidence for oxidative stress responses in AD+FA+ skin samples and its
link to skin barrier abnormalities in these subjects will be examined through the analysis of expression of
oxidative stress response enzymes, oxidative protein modifications in skin tape strip samples, and responses
to oxidants of the organotypic skin cultures from AD+FA+ subjects. The projects will provide new knowledge
about AD endotypes, biomarkers for disease assessment, and novel molecular targets for clinical disease
interventions.

Public health relevance
PROJECT NARRATIVE In response to RFA-AI-19-015, the purpose of this application is to establish an Atopic Dermatitis Research Network - Clinical Research Center (ADRN-CRC) at National Jewish Health (NJH) to conduct ADRN network-wide clinical research projects under the leadership of the ADRN-Leadership Center (ADRN- LC). In parallel, single-center clinical and mechanistic research at NJH will evaluate mechanisms underlying children with atopic dermatitis (AD) and food allergy as well as AD associated with eczema herpeticum. Our central hypothesis is that different phenotypes and endotypes of AD are associated with distinct defects in their skin barrier and cutaneous immune responses.